Resolving Spatiotemporal Dynamics of Recombinant Poliovirus Immunotherapy

Priming of antitumor immunity relies on a specialized subset of conventional Dendritic Cells (cDC1s), CD103+
DCs, that have unique capabilities of trafficking tumor antigens to lymph nodes for cross-presentation. The critical
role of cDC1s in cancer immune surveillance make them highly coveted targets for immunotherapy; however,
their scarcity, the difficulty of specifically engaging DCs, and the suppressive tumor microenvironment (TME)
pose severe obstacles. We are investigating immunotherapy with attenuated, recombinant poliovirus (PV),
PVSRIPO, because of the naturally evolved tropism of PV for DCs. In humans or chimpanzees, oral PV infection
leads to remarkably effective targeting of CD11c+DCs in peripheral (gastrointestinal) and lymphoid tissues.
PVSRIPO, engineered with an IRES from human rhinovirus type 2, lacks cytopathogenicity in normal cells, eg.
DCs. Rather, DC infection yields ‘sustained’ type-I interferon (IFN) responses elicited by specific viral dsRNA
patterns that engage the PV pattern recognition receptor (PRR) MDA5. Mechanistic investigations of PVSRIPO
treatment in ex vivo human tumor slices revealed that: (i) the main outcome is sustained type-I IFN release from
myeloid cell subsets in the non-malignant TME; (ii) PVSRIPO’s unique innate imprint provides optimal DC
activation stimuli for CD4+T cell TH1-polarization and CD8+T cell priming; (iii) PVSRIPO’s ‘PRR-contextualized’
IFN response induces polyfunctional GzmB+, IFNg+, T-bet+ antitumor CD8+T cells that control tumor growth after
adoptive transfer. We reported very promising Ph1 clinical trial results with PVSRIPO in challenging
indications: recurrent glioblastoma and recurrent, nonresectable melanoma. Our premise is that PVSRIPO
therapy recruits cDC1s, leads to local infection of these cells, induces migration to lymph nodes/spleen,
and stimulates tumor antigen cross-presentation via the intrinsic innate inflammatory signature it elicits.
We propose mechanistic and translational studies to gain insight into targeting of DCs by PVSRIPO, the way
sublethal infection of distinct myeloid subsets activates tumor antigen cross-presentation, and rational means of
enhancing DC engagement by intranodal virus administration. We propose the following Specific Aims: (1)
Unravel mechanisms of cDC1 recruitment, activation, and lymph node migration upon PVSRIPO infection of the
TME. (2) Determine the mononuclear phagocyte compartment(s) that mediate PVSRIPO antitumor effects; test
the roles of T cell-intrinsic IFN signaling and chemotaxis. (3) Reinforce cDC1 engagement by perinodal delivery
or upon infection of the PVSRIPO-reactive glioma myeloid infiltrate.
Significance: these studies explore a unique opportunity for effectively engaging CD103+DCs in tumor antigen
cross-presentation and CD8+T cell priming, based on the natural tropism for DCs and unique innate inflammatory
imprint of PVSRIPO. The long-term objective of this research is to provide means for re-instating effective cancer
immune surveillance in patients by overcoming tumor-associated deficits in DC function and CD8+T cell priming.

Public health relevance
Durable antitumor immunity requires presentation of tumor antigens by professional antigen presenting cells (APCs) for priming of antitumor T cell responses, but APC function is repressed in the immunosuppressive tumor microenvironment. This project will decipher the mechanisms of the unique immune stimulation provided by recombinant poliovirus, resulting from non-lethal infection and pro-inflammatory activation of APCs. The significance of this research is the potential to achieve significant clinical benefits for cancer patients by reinstating tumor immune surveillance.